Developing Mathmatical Framework to Uncover the Sequence of Genetic Events During

The recognition of cancer as a disease caused by the accumulation of genetic alterafions has motivated large-scale efforts to annotate the cancer genome for all human cancers. \Mien combined with computafional approaches that can distinguish statistically significant, recurrent events from the background

Public health relevance
Greater knowledge ofthe temporal sequence of events during tumorigenesis is important to understand the mechanism(s) through which cancer genes cooperate, to promote the discovery of new biomarkers for early cancer detection, and to select which